All of Us Pennsylvania (AOU PA) Research Program

As the first site to launch and enroll participants, the All of Us Pennsylvania (AOU PA) Program brings 10 years of experience, deep partnerships, data-driven operations, robust infrastructure, lessons learned, and dedicated staffing to accelerate progress on achieving the enrollment of one million participants across the United States. We have engaged communities and enrolled participants in 38 of the 67 counties in PA. As of October 10, 2023, we enrolled 41,558 Core participants (8.5% of the national cohort). New for AOU PA 2.0 will be the addition of community-based ambassadors - our AOU PA Navigators - and partner organizations - our Community Research Hubs. Navigators and Hubs will represent their communities on our Community Advisory Board, help develop messaging, promote and host engagement and enrollment activities, and directly communicate the value of All of Us through personal connections with their friends and neighbors. Our long-term objective for AOU PA 2.0 is to maintain our successful operations and to establish multiple AOU PA Navigators and Community Research Hubs who can operate independently with the support of the AOU PA Platform. They will focus on engaging and retaining participants across PA. At the same time, we will maintain current AOU PA enrollment activities in western and central PA, including those in rural communities. Specifically, we will: Aim 1. Conduct outreach and engagement activities with members of the communities in which enrollment will occur; and Aim 2. Engage, enroll, and retain participants from communities across PA. We will learn from community members how All of Us can best establish and communicate its trustworthiness. Our partnerships include the Pittsburgh Theological Seminary, several churches throughout the state, and independent community pharmacies. Our approach will ramp up AOU PA activities in new locations throughout Pennsylvania through personal engagement while expanding our current Enrollment activities in western PA.